Informatics Core

PROJECT SUMMARY - INFORMATICS CORE
The goal of the Informatics Core (IC) is to facilitate and enhance precision cancer research within the Cancer
Prevention-Interception Targeted Agent Discovery Program (CAP-IT) at Fox Chase Cancer Center (FCCC) by
providing expert biostatistics, bioinformatics, and data management support to CAP-IT investigators. Members
of the Core have substantial knowledge and experience in biostatistics and bioinformatics as applied to cancer
prevention research, including cancer risk assessment, biomarker analyses, and preclinical chemoprevention.
This highly interactive group of biostatisticians, bioinformaticians and informaticians will provide expertise in
experimental design that meets the requirements of rigorous science, statistical and bioinformatics analyses,
and informatics capabilities to ensure that all data are of high quality, stored in professionally managed
databases, and available for sharing with the CAP-IT Data and Resource Coordination Center (DRCC). It will
serve all CAP-IT projects, the Administration Core, and support future CAP-IT projects.
The specific goals of the IC are to: (1) Provide expertise in the design of experiments and studies, including
research proposal development, sample size determination, randomization procedures, and plans for final
analysis; (2) Perform statistical and bioinformatics analyses for CAP-IT investigators to assess validated
oncotargets for actionability, druggability, and/or feasibility for cancer prevention and/or interception; (3) Assist
with the writing of statistical and bioinformatics components of manuscripts and the interpretation and
presentation of results; (4) Provide computer-based tools to facilitate the storage and retrieval of data generated
in the proposed research; (5) Collaborate with the CAP-IT DRCC to populate a centralized CAP-IT database for
in-network data archiving and sharing; and (6) Perform bioinformatics analyses of molecular data from local data
resources, public databases, cell lines and biosamples from high-risk subjects to validate candidate
pathways/targets.
To accomplish these goals, the IC will leverage software from NCI-sponsored informatics initiatives (e.g.,
NCI Informatics Technology for Cancer Research) and mine publicly available data resources including the
Precancer Atlas and the NCI Clinical Proteomic Tumor Analysis Consortium. By providing quantitative skills and
data management and sharing capabilities, the IC will support the FCCC CAP-IT, facilitate achievement of
project aims, contribute to the design and conduct of new projects, and enable collaborations with the CAP-IT
Network though the DRCC.